AMBULATORY NON-INVASIVE URINARY INCONTINENCE MONITOR

Urinary incontinence, characterized by an involuntary loss of urine, affects over 10 million people in the United States alone. In addition to adversely affecting the patient's physical and psychological well- being, it costs nursing homes over $1 billion/year to deal with the problem. The goal of this project is to develop a low-cost, ambulatory instrument that can significantly reduce the number of accidents in incontinent patients. Using non-ionizing ultrasonic energy, the unit will continuously monitor the fullness of the patient's bladder and automatically set-off an audible alarm whenever a pre-established volume threshold is exceeded. The patient can then perform, or be helped to perform, a controlled voiding and minimize the risk of an accident. The device is also expected to improve the efficacy of both bladder and habit training programmes by providing a more direct mechanism for tangible feedback. During Phase I an experimental unit was developed, clinical tests conducted, and the feasibility of the concept proven. During Phase II, the goal is to complete the development of a clinically validated product prototype.